Single-Cell Multi-omics to Link Clonal Mosaicism (CM) Genotypes with Chromatin, Epigenomic, Transcriptomic and Protein Phenotypes

SUMMARY
Clonal outgrowths are observed across a wide range of normal human tissues. Clones harbor somatic
mutations in known cancer and other driver genes, and show evidence of positive selection. Nevertheless, how
these driver mutations alter the cellular states of cells to allow clones to outcompete wildtype counterparts
remains poorly understood. To date, efforts to chart clonal outgrowths in normal tissues have been largely
limited to genotyping. This is due to the fact that clones often affect a minority of cells in a sample, without
distinguishing cell surface markers or morphological features.
To address this challenge, we developed an array of multi-omic single-cell technologies that are capable of
capturing multiple layers of information (e.g., genotypes, transcriptomes, methylomes, protein expression) from
the same single cells. Moreover, we addressed the specific challenge of genotyping in scRNA-seq in single
cells at high throughput by developing genotyping of transcriptomes. Importantly, this technology turns the
admixture of mutant and wildtype cell from a limitation to an advantage, enabling the direct comparison of
mutant (“winner”) and wildtype (“loser”) cells within the same individual.
Capitalizing on our experience with single-cell technology development, we aim to extend the multi-omics
single-cell GoT (Genotyping of Targeted loci) toolkit to allow to interrogate how somatic mutations lead to
clonal growth advantage. First, we will develop and enhance our targeted single-cell genotyping in the context
of chromatin accessibility (GoT-ChA). This technology critically performs genotyping from DNA directly,
obviating limiting dependencies on mutated loci gene expression. Thus, it can be applied to extracted nuclei,
critical for the SMaHT initiative. We will build on GoT-ChA using nanobody tethered transposases to jointly
profile somatic mutations and histone modifications in single nuclei (GoT-EpiM). To capture transcriptional
changes together with somatic mutation genotyping and chromatin accessibility, we will further use
transposition of mRNA:cDNA hybrid in GoT-ChA-RNA. Finally, we will leverage recent advances that use
antibodies tagged with oligonucleotides to capture mutated loci, chromatin and intra-nuclear proteins such as
transcription factors (GoT-ChA-Pro). In aim 2, we will collaborate with genomic characterization centers to
apply these technologies to primary human samples to define how clonal mutations in normal tissues alter
chromatin, histone modifications, transcriptomes and protein abundance profiles to yield clonal outgrowth.
Our overarching goal is to invoke multi-omic comparisons at the single-cell level between wildtype and mutant
cells to comprehensively identify the underpinnings of fitness advantage in clonal outgrowth. The proposed
comprehensive GoT toolkit will enable to link, at high throughout single-cell genotypes with transcriptional,
protein, and epigenetic, with important implication in the study of clonal mosaicism as a harbinger of cancer, as
well as other human health outcomes.

Public health relevance
PROJECT NARRATIVE DNA mutations drive the outgrowth of small populations of cells in normal tissue, years before clinical diagnosis of cancer. However, how such mutations change cellular behavior to provide them with a competitive growth advantage over adjacent cells remains poorly understood. To address this gap in knowledge, we propose to apply and develop novel single-cell sequencing technologies to study the mechanisms underlying growth advantage in normal tissues.